Investigating PolQ-mediated alternative NHEJ in breast cancer

Chromosomal rearrangements are a hallmark of cancer cells and constitute a major pathway by
which genes that affect tumor initiation and progression become mutated. Such aberrancies can
result from defects in double-stranded break (DSB) repair. There are three major pathways of DNA
repair in mammalian cells – the well-studied homology recombination (HR) and non-homologous
end joining (NHEJ) pathways, and the poorly characterized, yet highly error-prone alt-NHEJ
(alternative-NHEJ) pathway. Genetic rearrangements consistent with alt-NHEJ have been noted
both in spontaneous and therapy-related tumors. In this proposal we will focus on polymerase theta
(Polθ), a low-fidelity enzyme that we recently identified as a key factor that mediates DSB repair by
alt-NHEJ. Given that HR-defective tumors are “addicted” to repairing DSBs via the alt-NHEJ
pathway, we hypothesize that the mutagenic activity of Polθ help establish a genomic landscape
that is conducive for aggressive tumor behavior. Additionally, we predict that deleting Polθ in tumors
with mutations in the breast cancer susceptibility (BRCA) genes will sensitize cells to DNA damage-
inducing therapeutic agents, including radiation therapy, cisplatin and PARP inhibitors. In the
second aim, we will investigate the impact of ATM and PARP1 on Polθ is recruited to break sites
and how the polymerase modulates damage sites to promote erroneous repair. In addition, we will
pursue a proteomic-based approach to highlight the full spectrum of molecular players involved in
alt-NHEJ. Ultimately, a full understanding of the mechanistic basis of alt-NHEJ will provide a better
understanding of the source of genomic instability during the course of malignancy and guide more
effective treatment strategies for the increasing number of patients with HR mutated tumors.

Public health relevance
Alt-NHEJ is a robust, yet poorly characterized DNA double stranded-break repair pathway that appears to alter the genome of cancer cells during disease progression. In this proposal we investigate the mechanism by which polymerase theta (Polq) promotes the activity of alt-NHEJ and test its impact on breast cancer progression, focusing primarily on tumors with mutations in the cancer susceptibility genes – BRCA1 and BRCA2. Our work will provide major insight into a critical mode of DNA repair and will guide more effective radiation and chemotherapy for an increasing number of HR defective tumors.